Administrative Core

RI-INBRE Administrative Core (AC) Project Summary
The overarching goal of the Rhode Island IDeA-Network of Biomedical Research Excellence (RI-INBRE) program is to improve institutional capacity for biomedical research excellence and student experiential training in the State of Rhode Island. The primary function of the RI-INBRE Administrative Core (AC) is to administer and coordinate all RI-INBRE operations, which can be broadly divided into two categories. The first category includes managing key research and training activities. This consists of the Developmental Research Projects Program, the Centralized Research Core Facility, the Data Science – Molecular Informatics Core, the Summer Undergraduate Research Fellowship program, the Student Research Program, the Teaching Postdoctoral Fellowship program, and the Workforce Development and Training program. The second category of AC activities is administrative and includes overseeing fiscal management and program assessment and coordinating the three governance committees: External Advisory, Steering, and Executive. In the renewal period, the AC will ensure the smooth operation of all program components, including program evaluation and reporting. The Student Research Program in the AC will intentionally recruit and train a talented pool of Rhode Island students via mentored research opportunities. Key initiatives in this renewal include expanding paid academic-year research opportunities for students and coordinating student skillset training in the Workforce Development and Training program. The AC will modify the existing Teaching Postdoctoral Fellowship program to be a cohort-based training program. Reorganizing the Faculty Sabbatical Program at Community College of Rhode Island will boost community college participation in RI-INBRE training programs. These efforts will enhance the research environment, promote faculty development, and bolster student training, all of which will encourage the creation of a dynamic and well-trained biomedical workforce and act as a catalyst for investment and entrepreneurship in the biomedical sciences in Rhode Island.